BIOMARKER CORE

Project Summary ? Biomarker Core Alzheimer's disease (AD) is a chronic disease that progresses through a lengthy asymptomatic period before entering a period of mild cognitive impairment (MCI) and dementia. Using current biomarker tools, we can determine with a fair degree of confidence whether or not AD-related pathology is present in a living individual. However, there remain major limitations in the capabilities of AD biomarkers, and there is a critical need for new biomarkers to overcome remaining barriers. The proposed Biomarker Core will support research activities in the Emory ADRC by pursuing four Specific Aims: 1) Establish an ethnoracially diverse biomarker collection in the Emory ADRC UDS cohort; 2) Perform assays for established CSF AD biomarkers and explore promising candidates; 3) Support network-wide neuroimaging initiatives and evaluate promising exploratory sequences; and 4) Establish standard genetic profiles for the UDS cohort and explore potential gene expression and epigenomic changes relevant to AD. The proposed Biomarker Core will provide a number of important enhancements to the research environment. Longitudinal collection of common datasets, including clinical information, CSF AD biomarkers, core genetic information, and standard brain MRI sequences, will provide foundations upon which new AD biomarkers can be tested, evaluated, and confirmed. Exploratory research in each of these areas should provide significant advances in CSF proteomics, new MR sequences, and genomic and epigenomic data. Lastly, the current proposal engages a group of talented investigators who will bring their expertise to the ADRC and the larger research community. Each of these elements advance the overall goals of the ADRC and will be fully integrated into existing Cores and local research environment.

Public health relevance
Narrative included in the Overall per PAR-17-020 instructions.